Microbial Glycobiology

In the last few decades, microbial glycobiology has become one of the most important sub-fields in both
microbiology and glycobiology as a result of the many critical roles that glycans play in microbial life,
pathogenesis and immune recognition. The 2024 Federation of American Societies for Experimental Biology
(FASEB) Scientific Research Conference (SRC) on Microbial Glycobiology will provide a forum for new and
exciting ideas from around the world on this important topic, as well as an opportunity for formal and informal
interactions amongst academic investigators, industry professionals and government scientists. Since 2004, the
FASEB SRC on Microbial Glycobiology has been the premier meeting for the study of microbial glycobiology.
The latest edition of this conference will be held September 8-12, 2024 at the Southbridge Hotel & Conference
Center in Central Massachusetts. Co-organizers of the meeting include Drs. Eric Sundberg (PI; Emory
University, USA), Nadine Samara (National Institute of Dental and Craniofacial Research, USA), Marcelo Guerin
(Institute of Molecular Biology of Barcelona, Spain) and Rupa Nagar (University of Dundee, UK). The conference
program will include 8 sessions and 31 invited speakers covering a wide range of important and timely sessions,
with an emphasis on unpublished data and ideas, including but not limited to glycans in bacterial cell envelope
biosynthesis and function, host-pathogen interactions in health and disease, roles of glycans in cell signaling,
microbiome modulation, chemical glycobiology and glycoengineering, glycoimmunology, and glycoconjugate
based vaccine development. To invest in the future of our field and enhance the knowledge exchange associated
with this meeting we will host “Meet the Expert” and “Career Development” workshops as well as invite 32 of our
best abstract submissions to present short talks. Poster sessions will be timed to enhance interaction amongst
attendees to enable stimulating discussions. We have hard-wired Diversity, Equity, Accessibility, and Inclusion
(DEAI) into our conference program and activities, as reflected in our gender-balanced planning committee and
invited speaker list. To further support DEAI at the conference, we request funds to support registration and
travel awards for trainees, as well as childcare awards to individuals attending the conference with their children.
We will award at least half of all of these awards to trainees who self-identify as women, individuals from
underrepresented populations and researchers with disabilities. The 2024 FASEB SRC on Microbial
Glycobiology will provide the ideal platform for the exchange of cutting-edge ideas, novel technologies and
exciting new developments in the field of microbial glycobiology.

Public health relevance
Microbial glycobiology is a burgeoning field of research that directly informs and impacts some of the greatest health challenges of our time, including viral pandemics, antibiotic resistance and the development of novel immunotherapeutic antibodies. The 2024 Federation of American Societies for Experimental Biology (FASEB) Scientific Research Conference (SRC) on Microbial Glycobiology is the only international conference to focus exclusively on these critical facets of biomedical science and will bring together academics, industry professionals and government scientists in a productive, open, and exciting environment for the free exchange of ideas and concepts. Beyond advancing the field of Microbial Glycobiology, this conference will provide exceptional professional development opportunities for trainees and early-career investigators and will set the standard for a diverse and inclusive research community.